Admin-Core

PROJECT SUMMARY/ABSTRACT
The Administrative and Data Management (Admin) Core ensures that the Indiana University School of
Medicine Purdue University TaRget Enablement to Accelerate Therapy Development for Alzheimer's Disease
(IUSM-Purdue TREAT-AD) Center achieves its overall strategic mission as well as specific project aims and
milestones. The Admin Core oversees all administrative and integrated scientific functions of the TREAT-AD
Center and will execute its duties with guidance from a Center Steering Committee (CSC) and External Advisory
Board (EAB). The Admin Core will provide leadership and oversight in the following key areas: (1) Input to project
portfolio recommendations and priorities for advanced target validation and drug discovery; (2) Technical
strategy for implementation of TREAT-AD Center objectives and the integrated management of Core activities
to deliver on project milestones, including functional coordination with other centers and collaborators; (3) High-
level resource decisions and trade-offs, removing bottlenecks, and implementing alternative strategies when
necessary to ensure success; (4) Regular communication and input to the CSC and EAB; and (5) Ownership of
timely Target Enablement Package (TEP) assembly and distribution. Further, the Admin Core will ensure that
discoveries made in one area of the TREAT-AD Center will benefit the entire Center, leading to efficiencies in
time and cost. Finally, the Admin Core will execute its overarching strategic management, evaluation, and
fiduciary duties through biweekly Admin Meetings and select meetings with the NIH, EAB, and CSC, along with
other organized administrative and scientific meetings of TREAT-AD Center investigators, staff, collaborators,
and advisors.